Discovery of First-in-class WDR5 PROTACs as a Novel Therapeutic Strategy for MLL-rearranged Leukemias

PROJECT SUMMARY
The main objective of the parent project is to develop WDR5 small-molecule degraders as anticancer
therapeutics. WD40 repeat domain protein 5 (WDR5), which functions an essential subunit of the MLL histone
methyltransferase complex, is critical for gene transcription regulations and essential for sustaining oncogenesis
in human cancers. WDR5 is also implicated in Alzheimer’s Disease (AD), and WDR5 inhibitors are efficacious
in improving prefrontal cortex synaptic function and memory-related behaviors in AD mice. The parent project
does not focus on AD. This administrative supplement is in response to the Notice of Special Interest NOT-AG-
22-025, Alzheimer’s-Focused Administrative Supplements for NIH Grants that are Not Focused on Alzheimer’s
Disease. Some cancer patients also suffer from AD, a devastating neurodegenerative disorder, which currently
has no effective disease-modifying therapeutics. Synaptojanin 1 (synj1), the main phosphoinositol bisphosphate
degrading enzyme in the brain and synapses, plays a critical role in AD pathology. Increased synj1 expression
and activities have been associated with cognitive decline and pathological processes of AD. Synj1 is also
implicated in cancer. It is overexpressed in various cancers, and high expression of synj1 correlates with poor
prognosis in cancer patients. In our preliminary studies, compounds that lower the synj1 protein level have been
discovered. The lead synj1-lowering compounds were efficacious
in several AD mouse models. In this
administrative supplement, we propose to conduct a lead optimization campaign to generate optimized synj1-
lowering compounds with
improved potency, selectivity and brain penetration. The synj1-lowering compounds
generated in this administrative supplement could ultimately be developed into effective therapeutics for the
treatment of AD, which will also benefit cancer patients who suffer from AD. These synj1-lowering compounds
could also be useful anticancer therapeutics.

Public health relevance
PROJECT NARRATIVE In this administrative supplement, we propose to optimize synj1-lowering compounds for the treatment of Alzheimer’s Disease (AD). These agents will also benefit cancer patients who suffer from AD. They could also be useful anticancer therapeutics.